Regional extracellular matrix remodeling: multiscale imaging and mechanics.

Project Summary
Cells have a dynamic and reciprocal relationship with their extracellular matrix (ECM). Cells synthesize,
degrade, and rearrange local ECM proteins and molecules even as the physical properties of the ECM, (including
its stiffness, density, and orientation), regulate cell phenotype, behavior, and communication. Disease and injury
disrupt this dynamic relationship causing cells to produce local patterns of ECM remodeling that can be
pathologic, such as fibrosis, or inadequate, leading to tearing or a persistent wound. Understanding ECM
heterogeneity represents a key opportunity to enhance knowledge of how disease and injury develop and
progress. Therefore, my research program focuses on increasing the rigor and reproducibility of approaches to
capture ECM remodeling. Specifically, we ask (1) how do ECM geometry and structure vary regionally at multiple
scales? and (2) how does heterogeneity influence a tissue’s local and global load-bearing function?
My research program answers these questions by addressing critical limitations in the visualization and
mechanical characterization of heterogeneous ECM. Although groundbreaking techniques have emerged that
enable micro and even nano-scale ECM imaging, a crucial tradeoff is field of view or sample size. For example,
laser scanning microscopy provides unparalleled visualization of collagen, the most abundant ECM protein in
the human body, capturing fiber dimensions and morphology with clarity far beyond traditional microscopy.
However, it covers, at most, a couple hundred microns in each direction. Therefore, a critical challenge in
applying high-resolution imaging to heterogeneous pathologic samples involves selecting this micron-sized
imaging window from the centimeters of available tissue. Our group is at the forefront of increasing rigor and
repeatability in this field, advancing low-resolution imaging, image segmentation, and analysis automation.
Another barrier to investigating ECM heterogeneity is the lack of experimental protocols and analysis tools to
quantify spatial variations in mechanical properties
. Inverse methods have addressed technical challenges in
this area but face limited adoption due to their complex mathematical techniques and specialized codes. We will
address this gap using a novel experimental system to generate a repository of full-field measurements on a
range of heterogenous samples. Then, we will create sample-specific finite element models using a popular
open-source software and encourage the inverse mechanics community to outperform us. To study pathologic
remodeling under highly controlled conditions, we will also build a specialized clamping system that connects
cell-seeded tissue-engineered constructs to our mechanical and quantitative polarized light testing systems.
Our research program addresses specific challenges in quantifying regional differences in ECM
remodeling to address fundamental questions about how pathology develops and progresses. Ultimately,
insights from this program will improve disease detection and prognostication as well as localized treatment.

Public health relevance
Project Narrative Cells have a dynamic and reciprocal relationship with their extracellular matrix - simultaneously synthesizing, degrading, and rearranging this matrix as it regulates their phenotype, behavior, and communication. Disease and injury disrupt this relationship, triggering local fibrosis or matrix weakening, which results in functionally important but challenging-to-quantify heterogeneity in tissue structure and mechanics. To gain insight into the progression and implications of pathologic remodeling we will improve the rigor and reproducibility of the multiscale imaging and mechanical testing of heterogeneous soft tissues.